Lipidic drivers of organelle function and dysregulation

Contact PD/PI: BUDIN, ITAY
352-(&7 6800$5<
/LSLGV UHSUHVHQW D GLYHUVH FODVV RI ELRPROHFXOHV WKDW DUH WKH EXLOGLQJ EORFNV RI FHOO PHPEUDQHV ,Q UHFHQW \HDUV
DOWHUDWLRQV LQ OLSLG FRPSRVLWLRQ KDYH EHHQ LGHQWLILHG DV KDOOPDUNV RI QXPHURXV GLVHDVHV UDQJLQJ IURP W\SH
GLDEHWHV WR QHXURGHJHQHUDWLYH GLVRUGHUV +RZHYHU XQGHUVWDQGLQJ WKH IXQFWLRQDO UROHV RI EXON PHPEUDQH OLSLGV
KDV ORQJ EHHQ D FKDOOHQJH LQ SDUW GXH WR WKH GLIILFXOWLHV RI PDQLSXODWLQJ DQG LPDJLQJ WKHP LQ FHOOV 2XU ODERUDWRU\
DSSOLHV JHQHWLF DQG FKHPLFDO WRROV WR VWXG\ OLSLG IXQFWLRQ DQG GHYHORS ELRSK\VLFDO PRGHOV IRU PHPEUDQH
DVVRFLDWHG FHOOXODU SURFHVVHV 7KH SURSRVHG UHVHDUFK SURJUDP ZLOO FDUU\ RXW WKLV DSSURDFK WR LGHQWLI\ KRZ WZR
GLVHDVHDVVRFLDWHG OLSLG SHUWXUEDWLRQV DOWHU WKH EHKDYLRU RI FHOOXODU FRPSDUWPHQWV ,Q WKH ILUVW WKUXVW ZH ZLOO XVH
HIIHFWV RI VDWXUDWHG SKRVSKROLSLGV RQ PHPEUDQH YLVFRVLW\ WR XQFRYHU KRZ VWUXFWXUH DQG G\QDPLFV FRQWURO
UHVSLUDWRU\ PHWDEROLVP 6SHFLILFDOO\ ZH ZLOO HQJLQHHU LQQHU PLWRFKRQGULDO PHPEUDQH FRPSRVLWLRQ LQ ERWK \HDVW
DQG PDPPDOLDQ FHOO OLQHV DQG XVH WKLV SHUWXUEDWLRQ WR GLVVHFW WKH FRQWULEXWLRQV RI GLIIXVLRQ DQG VXSUDPROHFXODU
DVVHPEO\ WR WKH HOHFWURQ WUDQVSRUW FKDLQ 7KLV HIIRUW ZLOO XQFRYHU WKH IXQFWLRQ RI FRQVHUYHG IHDWXUHV RI PDPPDOLDQ
PLWRFKRQGULD VXFK DV UHVSLUDWRU\ VXSHUFRPSOH[HV DQG WHVW KRZ LQFUHDVHV LQ VDWXUDWHG OLSLGV FDXVHG E\
PHWDEROLF GLVRUGHUV FRXOG GLUHFWO\ FRQWULEXWH WR PLWRFKRQGULDO G\VIXQFWLRQ ,Q WKH VHFRQG WKUXVW ZH ZLOO XVH D
JHQHWLF V\VWHP WR LQWHUURJDWH WKH IXQFWLRQ RI GHR[\VSKLQJOLSLGV QRQFDQRQLFDO SURGXFWV RI VHULQH
SDOPLWR\OWUDQVIHUDVH WKDW KDYH EHHQ DVVRFLDWHG ZLWK VHYHUDO JHQHWLF DQG PHWDEROLF GLVRUGHUV :H ZLOO IRFXV RQ
KRZ V\QWKHVLV RI GHR[\VSKLQJOLSLGV G\VUHJXODWHV WKH HQGRPHPEUDQH V\VWHP LQ UHWLQDO SLJPHQW HSLWKHOLXP
FHOOV ZKLFK KDYH EHHQ OLQNHG WR DGXOWRQVHW EOLQGQHVV FDXVHG E\ GHR[\VSKLQJOLSLG DFFXPXODWLRQ 'HYHORSPHQW
RI QHZ LPDJLQJ DSSURDFKHV ZLOO EURDGHQ WKH LPSDFW RI WKLV WKUXVW WR WKH HPHUJLQJ ELRPHGLFDO UROHV IRU WKHVH
HQLJPDWLF OLSLGV ,I H[HFXWHG WKH UHVHDUFK SURJUDP ZLOO WKXV JHQHUDWH PRGHOV IRU WZR VHWV RI OLSLGV PROHFXOHV DQG
WKHLU FHOOXODU SRLQWV RI DFWLRQ LQ ERWK KHDOWK\ DQG GLVHDVHG FHOOV 2XU ORQJWHUP JRDO LV WR XQGHUVWDQG KRZ FKDQJHV
LQ OLSLG FRPSRVLWLRQ DFURVV RUJDQHOOHV FHOOV DQG WLVVXHV DULVH DQG IXQFWLRQ DQG XVH WKLV NQRZOHGJH WR XQFRYHU
WKH PROHFXODU PHFKDQLVPV XQGHUO\LQJ PHPEUDQH ELRORJ\
Project Summary/Abstract Page 6

Public health relevance
PROJECT NARRATIVE The proposed research program will utilize genetic and biophysical approaches to elucidate the organelle specific roles of membrane lipid components relevant to human health. In the first thrust, the ability of unsaturated lipids to act as viscous and mechanical regulators of mitochondrial respiration will be tested. In the second, the mechanisms by which non-canonical sphingolipids dysregulate endomembrane structure and function will be determined.